Structure and function of myosin binding protein-C in skeletal muscles

Abstract.
The overall goal of this research is to understand how myosin binding protein-C (MyBP-C)
regulates skeletal muscle contraction and how mutations in the genes encoding slow and fast MyBP-
C (MYBPC1 and MYBPC2, respectively) cause congenital skeletal muscle diseases such as distal limb
contractures and myogenic tremors. Until now, cardiac MyBP-C (cMyBP-C, encoded by MYBC3) has
received intense research attention because mutations in MYBPC3 account for the majority of
mutations leading to hypertrophic cardiomyopathy, however far less is known about the 2 skeletal
muscle paralogs of MyBP-C despite their connections to disease. This is in part because slow and fast
MyBP-C are co-expressed in most muscle types and MYBPC1 undergoes extensive exon shuffling and
post translational modifications that alter its function. Furthermore, the different sMyBP-C and fMyBP-
C paralogs, splice variants, and post translational modifications all are thought to differ in their functional
effects, but because of overlapping patterns of expression it has proven nearly impossible to
disentangle the distinct functional and structural effects of the individual MyBP-C variants in working
skeletal muscles. Here, we overcome this challenge by using a novel “cut and paste” method developed
exclusively in the PI’s lab that allows us to selectively modify sMyBP-C, fMyBP-C, or both at their native
positions in working sarcomeres to systematically determine distinct functional effects of each paralog,
splice variant and mutation on contraction and relaxation in any skeletal muscle (Aim 1). In Aim 2 we
combine the cut and paste method with X-ray diffraction measurements to determine the unique
structural effects of paralogs, variants, and mutations on both thick and thin filament structure in both
active and relaxed sarcomeres. Results from this study will give us unprecedented insights into the
structural and functional effects of the MyBP-C family of proteins in skeletal muscle, paving the way for
the design of therapeutic treatments that selectively target skeletal MyBP-C paralogs to treat inherited
contractures and tremors.

Public health relevance
Project narrative. Myosin binding protein-C (MyBP-C) is a family of muscle regulatory proteins that have been increasingly linked to genetic skeletal muscle diseases including those that cause clubfoot and myogenic tremors, but the role of MyBP-C in normal muscle function and the mechanism(s) by which mutations cause disease are still poorly understood. Here, we will use a new approach developed exclusively in the PI’s lab to selectively modify MyBP-C in contracting muscle sarcomeres to assess structural and functional changes caused by mutations and variations in protein expression. Results from this study will provide critical new insights into how MyBP-C regulates sarcomere structure and function with the potential to identify new targets for muscle therapeutics.